Regulatory mechanisms governing Th17 cell effector identity and plasticity

PROJECT SUMMARY
T helper (Th) cells are CD4-expressing T lymphocytes that specialize into several subclasses to support
distinct immune responses. Among this diversity, IL-17A-producing inflammatory Th17 cells stand out as
unique by virtue of their high level of inherent plasticity. Indeed, this subset that normally functions in mucosal
immunity against bacteria and fungi can easily adopt features of other T helper subsets when environmental
conditions change. While this feature can be advantageous towards clearance of infections, dysregulated Th17
cell function has been implicated in numerous autoimmune conditions, including inflammatory bowel disease,
and multiple sclerosis. Moreover, Th17 cell plasticity exhibited in the context of inflammatory disease takes on
Th1-like traits, such as expression of IFN and T-bet, that drive increased pathology. In previous work, we
identified AP-1 factor JunB as a critical regulator of Th17 cell identity that both activates the Th17 cell program
while restraining inappropriate plasticity to the Th1 lineage fate. In our current funded studies, we extended the
scope of JunB function to a related type 3 lineage—IL-17A-producing  T (T17) cells—where it similarly
limits type 1 effector conversion in the context of infection-induced intestinal inflammation. The conservation of
JunB function among type 3 lineage T cells underscores the central importance of the AP-1 regulator as a
gatekeeper of type 1 plasticity. While much is known about the signals and transcription factors that drive Th17
cell differentiation, the mechanisms controlling Th17 cell flexibility are less understood. We hypothesize that
reversible silencing of alternative effector programs governs the Th17 cell poised state and facilitates type 1
effector plasticity in response to environmental triggers. Here, we exploit the function of JunB as a
transcriptional repressor of alternative fates to probe the cis and trans silencing regulatory network that
governs Th17 cell type 1 effector conversion. To this end, in Aim 1, we will define the silencer regulatory
network governing Th17 cell effector flexibility. For this, we will use a novel in vivo high throughput reporter
assay for large-scale identification of silencer cis elements with regulatory roles in Th17 cell plasticity induced
by intestinal Citrobacter rodentium infection. We will validate candidates using CRISPR/Cas9 deletion in vitro
and in mice, including a novel JunB-dependent silencer Ifng CNS+18 that limits IFN expression in Th17 cells.
In Aim 2, we will apply advanced proteomics approaches to characterize activating and repressive JunB
protein complexes in Th17 cells. For this, we will use JunB TurboID proximity-labeling and affinity purification
of total and chromatin-associated complexes in combination with CRISPR/Cas9 screening to identify and
validate novel coregulators of Th17 cell plasticity. Taken together, the proposed work will fill an important gap
in knowledge concerning the cis and trans molecular mechanisms governing Th17 cell identity and plasticity.

Public health relevance
PROJECT NARRATIVE (RELEVANCE) T helper 17 (Th17) cells are critical to immunity at mucosal surfaces such as the intestine, however, these pro- inflammatory cells have also been implicated as mediators of autoimmunity in conditions such as Inflammatory Bowel Disease, Multiple Sclerosis, Rheumatoid Arthritis, and Psoriasis. Th17 cells are extremely plastic and their conversion into IFN-producing Th1-like cells results in exacerbated inflammation and disease. This project investigates the mechanisms that control Th17 cell identity and plasticity that can be exploited in autoimmune disease to extinguish damaging inflammatory responses.